DEVELOPMENT OF DETOXIFIED PERTUSSIS TOXIN FOR ACELLULAR WHOOPING COUGH VACCINE

Whooping cough is caused by an infection of the respiratory tract with Bordetella pertussis bacteria. This disease is effectively controlled by the current vaccine which consists of killed whole B. pertussis cells. Though efficacious, the present vaccine produces unacceptable side effects. The major protective antigen in whooping cough vaccines is pertussis toxin. Clinical trials of acellular pertussis products strongly indicate that pertussis toxin will be a necessary and perhaps sufficient component of any new vaccine. Chemically "inactivated" pertussis toxin vaccines have been produced with reduced side effects and reasonable efficacy, however, residual activity may exist. Through our gene expression experiments we discovered a molecular approach for inactivation of pertussis toxin. Using site-specific DNA mutagenesis, the S1 subunit was modified by either a single or double amino acid substitution. These mutations virtually eliminated toxic activity, yet the immunogenic protective epitope was retained. We have devised several methods to transfer these genetic changes into the chromosome of B. pertussis, thus creating several new mutant strains. Using these new mutant strains, a genetically detoxified pertussis toxin molecule has been produced. This nontoxic holotoxin has strong immunoprotective properties and can be used as a vaccine antigen without chemical inactivation. Characterization of the biological activities associated with these new strains is currently underway in our laboratory and at the National Institute of Health in Tokyo, Japan.